Prazosin Treatment for Alcohol Use Disorder with Alcohol Withdrawal Symptoms

Project Abstract
Alcohol Use Disorder (AUD) is a chronic relapsing illness in which alcohol withdrawal symptoms (AW) are
associated with greater treatment failure risk and higher rates of relapse and alcohol intake. Efficacy of current
approved medications in AUD are modest, and none have been shown to be efficacious in those with AW.
Thus, there is great need to develop and evaluate treatments to address specific prognostic indicators of high
relapse and treatment failure to reduce the associated burden of AUD. Based on this previous clinical
research, we hypothesized that in AUD patients with AW (AUD+AW), PR (16 mg/day) compared to PBO will
significantly improve alcohol use outcomes, craving and also reduce associated anxiety and depression
symptoms and improve physical health (SBP and liver enzymes) functioning and patient-related outcomes
during the course of the trial and with enduring effects during over a 3 month follow up period, thereby
validating AW as a prognostic indicator both of Prazosin efficacy and in AUD treatment outcome. A 12-week
Phase II, single site, randomized clinical trial of Prazosin (PR: 16 mg/day, t.i.d dosing) is proposed in 150
treatment seeking men and women with AUD+ AW (3 or more symptoms) to address the following specific
aims: Aim #1: To evaluate the effects of PR vs PBO on the primary alcohol use outcome of percent of
subjects with no heavy drinking day (PSNHDD) and secondary drinking outcomes of %heavy drinking day
(HDD%), any drinking day (DD%) and average drinks/day (AvgD) in AUD+AW patients. Aim #2: To assess the
effects of PR vs PBO on other secondary stress-related outcomes of alcohol craving, depression and anxiety
symptoms during the trial. Aim #3: To assess enduring short-term treatment effects of PR versus PBO on
primary and other secondary outcomes at 1- and 3- month post-treatment follow-up time points. Exploratory Aim
1: To assess the effects of PR vs PBO treatment during the trial and at follow up on secondary physical health
(SBP/DBP and liver enzymes) and patient-reported functioning outcomes. Exploratory Aim 2: To explore
whether pre-treatment patient characteristics (gender, adversity/trauma history and lifetime PTSD) influence
Prazosin effects on primary and secondary alcohol use and related outcomes. Prazosin is a commonly
prescribed medication that most clinicians feel comfortable using. If successful, findings will provide important
efficacy data on Prazosin’s role in AUD+AW treatment and in related secondary psychological and physical
health outcomes. It will further validate AW at outpatient treatment entry as a prognostic indicator for AUD
treatment and for Prazosin use among AUD+AW subgroup of patients. It will also support development of the
precision medicine goal of providing specific treatment options for AUD patients with AW and stress-related
pathophysiology to improve their AUD treatment outcomes.

Public health relevance
Project Narrative Alcohol use disorder (AUD) is a serious public health problem, and current treatments do not address alcohol withdrawal symptoms (AW) and related stress pathophysiology that are associated with high relapse risk and treatment failure in AUD. The proposed research will enroll the more severe subgroup of AUD+AW and test the efficacy of Prazosin in a 12-week randomized controlled trial for improving alcohol use outcomes, other psychological and physical health functioning and patient related outcomes. Positive findings will support the use of Prazosin to reduce heavy drinking outcomes and improve functioning among individuals with AUD and alcohol withdrawal and related stress pathophysiology.